A Universal Fungal Transposase System for Increasing Natural Product and Protein Titers

PROJECT SUMMARY. Fungal natural products (NPs) and enzymes are valued for their unique and diverse
bioactivities. Flagship NPs command hundreds of millions of dollars in agricultural and tens of billions in
pharmaceutical markets per year globally, illustrating a broad appetite for fungal molecules across disparate
industries. Global markets for all microbial NPs are projected to exceed $300 billion (USD) by 2030. Fungal
enzymes represent over half the worldwide enzyme market, which is projected to exceed $10 billion by 2031.
Despite recent progress in our computational understanding of the breadth of chemical and enzymatic diversity
encoded in fungal genomes, limitations in existing synthetic biology expression tools have stymied rapid access
to new and improved products. The current bottleneck in developing novel fungal products is specifically at the
strain engineering step as it is routinely observed that heterologous strains do not produce enough product, even
for something as fundamental as molecular detection or functional screening, let alone scaleup for industrial
production.
This research proposal seeks to simplify and shorten development timelines for generating stable, high titer
heterologous production strains by integrating recent advances in fungal synthetic biology tools with proven
eukaryotic transposase technologies. This approach would overcome limitations seen with existing methods that
result in low titer performance. Leap-InTM and piggyBacTM transposase products have revolutionized mammalian
cell culture industries by rapidly engineering high titer production-worthy strains by stably integrating multiple
copies of an intact transposon payload, regardless of size or sequence content, by a cut-and-paste mechanism
multiple times throughout the genome preferentially into active chromatin. With this technology, the production
of stable antibody producing cell lines now only takes a few months rather than a year or more. Unlike anything
on the market currently, the proposed Fungal Transposase engineering platform will leverage these benefits to
directly address quantitative and qualitative limitations in heterologous strain performance by ensuring payloads
remain intact, stable, and as transcriptionally active throughout the genome as possible.
Supporting this objective are the following specific aims: (1) Build a Fungal Transposase toolkit for heterologous
overexpression, and (2) Overexpress NP BGCs by Fungal Transposase-enabled multiple integrations. These
aims will address the technical challenges inherent to adapting a mammalian cell engineering technology to the
difficult filamentous fungi and assess its capacity for engineering improved high titer strains. This proposal can
be completed using established molecular techniques and leveraging known reporter and NP controls: luciferase
as a single enzyme product to evaluate copy number-based transcriptional overexpression, and NP BGCs
encoding imizoquin and pestalamide which have been demonstrated to heterologously express in the model
organism Aspergillus nidulans.

Public health relevance
PROJECT NARRATIVE. Fungal natural products and enzymes play a significant role in human health and well- being, and the need for these diverse bioactive molecules is accelerating as our population continues to grow exponentially on a rapidly changing planet. There remains a significant unmet need for innovative approaches to mine and produce novel fungal products quickly, reliably, and at sufficient titer. This application proposes developing a platform that directly addresses this need by merging existing technologies from other fields in a novel way for the simplification of fungal strain engineering with the express purpose of quickly attaining higher fungal product yields for characterization, testing, and manufacturing.